Examining the longitudinal impact of circulating endocannabinoid levels on neurocognition, impulsivity, and early cannabis use patterns in youth enrolled in the ABCD Study

PROJECT SUMMARY
The endogenous endocannabinoid (eCB) system includes cannabinoid receptor 1 (CB1R), CB2R, and two
endogenous ligands (N-arachidonoylethanolamine, AEA and 2-arachidonoylglycerol, 2AG) and
endocannabinoid lipid mediators (oleoylethanolamide, OEA, palmitoylethanolamide, PEA, and 2-oleoylglycerol,
2OG). Animal findings demonstrate that the eCB system undergoes dynamic changes during adolescence and
suggest a significant role in neurodevelopment, especially in CB1R-dense prefrontal, parietal, striatal and
limbic brain regions. Research in adults have found that eCB system signaling modulates executive functioning
(i.e., impulsivity, behavioral approach), reward response, and affective processing. Thus, there is strong
preclinical evidence that the eCB system plays a substantial role in neuronal activity and neurodevelopment
and disruption of or reduced eCB signaling during adolescence may result in abnormal neurocognitive
development, risk for psychopathology, and increased risk for substance use, especially cannabis (CAN) use.
Despite this rich preclinical evidence, no study to date has examined the longitudinal role of the eCB system on
neurocognition or early onset cannabis and other substance use ex vivo in human youth due to the inherent
challenges in employing invasive techniques [i.e., PET studies]. However, there is now an available bioassay
to measure circulating eCBs in serum collected from blood, that can be measured ex vivo in humans. Serum
AEA and 2AG levels reflect both peripheral system synthesis and overflow from the brain and animal evidence
has shown that circulating and brain eCB concentrations are robustly and significantly correlated. Further, adult
studies have found significant associations between circulating serum eCBs and executive functioning, stress
response, reward signaling, affective processing and regular CAN use. Notably, longitudinal studies relating
serum eCB levels and neurocognitive and CAN use outcomes have not yet been conducted in youth- despite
convincing preclinical evidence that the impact may be greater during these critical neurodevelopmental years.
The proposed R01 project will expand upon our cross-sectional pilot R21 study and be the first to establish the
longitudinal effects of circulating eCB levels and changes over time on neurocognitive, impulsivity/behavioral
approach, and early CAN, alcohol and other substance use development in a subset of 2000 youth as they age
from 13-20 years old who are already enrolled in the longitudinal Adolescent Brain Cognitive Development
(ABCD) Study (8 research sites). We will also examine sex differences in these effects.

Public health relevance
PROJECT NARRATIVE Preclinical animal findings have demonstrated that the endogenous endocannabinoid (eCB) system plays an important role in neuronal signaling and development, especially during the adolescent years. Adult studies have found a link between eCB levels and outcomes related to neurocognition, personality and substance use, although these studies have never been conducted in human youth. This study addresses this gap in knowledge by examining the longitudinal role of eCB levels and neurocognitive, impulsivity, and early cannabis and other substance use outcomes over time in a subset of 2,000 youth, as they age from 13-20, who are enrolled in the longitudinal Adolescent Brain Cognitive Development (ABCD) Study.